Arterial Inflammation and Coronary Microvascular Dysfunction among Women with HIV: Missing Pieces to the MI Risk Puzzle

7. Project Summary/Abstract
In the US, nearly half of the 1.1 million people with HIV (PHIV) are aged 50 and older. This aging HIV
population is uniquely vulnerable to select cardiovascular (CV) comorbidities, including myocardial infarction
(MI). Women with HIV (WHIV) face the highest HIV-attributable risk of MI: a 3-fold increased risk vs. non-HIV-
infected women. Given the public health impact of MI-related morbidity and mortality, strong imperatives exist
to better understand mechanisms underlying MI risk among WHIV. Characterization of pathways predisposing
WHIV to MI will enable the development of rational MI prevention strategies and the targeted delivery of such
strategies to women in need. Through this proposal, our interdisciplinary team will combine state-of-the-art
non-invasive CV imaging with detailed molecular immune cell and endothelial cell phenotyping to define
mechanisms predisposing WHIV to MI. Studying a prospectively recruited cohort of WHIV vs. non-HIV-infected
women, we will explore a well-substantiated central hypothesis: Among women, HIV infection prompts
systemic monocyte activation and endothelial cell pathology, predisposing to increased arterial inflammation.
Arterial inflammation and endothelial cell pathology, in turn, promote not only non-calcified epicardial artery
plaque but also coronary microvascular dysfunction. We plan to show that arterial inflammation and coronary
microvascular dysfunction represent thus far neglected but potentially critical mechanisms of HIV-attributable
MI risk among women – missing puzzle pieces (Aims 1-2). We also aim to delineate - on a molecular level -
how circulating monocyte and vascular endothelial cell phenotypes differ among WHIV vs. non-HIV-infected
women. Finally, we will investigate how pathologic monocyte/endothelial cell phenotypes may engender
arterial inflammation, non-calcified epicardial artery plaque, and/or coronary microvascular dysfunction among
WHIV (Aim 3). Confirmation of our central hypothesis will introduce a paradigm-shift in conceptualizing HIV-
attributable MI risk among women – focused not only on macroscopic atherosclerotic plaque in the epicardial
arteries but also on arterial inflammation and coronary microvascular dysfunction. Moreover, our work on
mechanistic pathways engendering CV pathology among WHIV will inform the design of future research in the
field. Specifically, we anticipate our work will suggest that strategies to mitigate monocyte honing to the
vasculature (e.g. CCR2 blockade) or strategies to improve vascular endothelial cell function (e.g. metformin)
should be tested for ability to forestall or reverse the key pathologic processes driving MI risk among WHIV.
Further, our work will enable future studies on cardioprotective interventions among WHIV to be powered to
the most appropriate CV surrogate risk endpoints – those which are found in this study to differ most strikingly
among women with vs. without HIV. As MI is a highly-morbid, age-related comorbidity to which WHIV are
particularly vulnerable, our work will have significant implications to improve cardiovascular disease prevention
among at-risk women aging with HIV.

Public health relevance
8. Project Narrative: HIV infection makes women more vulnerable to heart attack. We will assess processes which may contribute uniquely to heart attack risk among women with HIV (vs. women without HIV). This will help us identify strategies to prevent heart attacks in women with HIV.